Purchase and Installation of New Equipment for the WNPRC ABSL-3 Suite

Project Summary/Abstract
Using funding from two administrative supplements awarded by the NIH Office of Infrastructure Programs, the
Wisconsin National Primate Research Center (WNPRC) contracted bioBubble, Inc. (Fort Collins, Colorado) to
design, manufacture, and install soft-wall HEPA-filtered enclosures in quarantine rooms 152 and 156 at our
Blue Mounds Quarantine Facility. These enclosures contain two Animal Biosafety Level-3 (ABSL-3) housing
spaces large enough to hold a total of 44 adult Old World monkeys and an adjacent Biosafety Level-3
procedure/laboratory space large enough to hold a downdraft exam/necropsy table, biosafety cabinet, digital
radiography unit, and sample freezers and represent the first functional ABSL-3 suite at the WNPRC in its 61-
year history.
The specific aims of this administrative supplement request are to purchase the pieces of equipment listed
below and to perform minor alterations to the new WNPRC ABSL-3 suite to install this equipment.
1. A Model PT-SR-24C: 24" X 36" X 36" chamber pass-thru sterilizer from Consolidated Sterilizer
Systems
2. A Bioquell ProteoQ vaporized hydrogen peroxide decontamination from Ecolab
3. Two Dynaco Streamline high speed doors from Paul Reilly Company
4. Physiotel large animal telemetry system from Data Sciences International
5. Vivid IQ Ultra Pro V204 tabletop ultrasound unit from Sound
6. Fourteen power unit covers from bioBubble
Purchasing and installing the equipment listed above will further augment biosafety practices within the suite
and will improve the quality of veterinary care performed and data collected from the nonhuman primates
housed in the suite.

Public health relevance
Project Narrative This proposal requests funding for the purchase of equipment and minor alterations to the Wisconsin National Primate Research Center’s newly created Animal Biosafety Level-3 suite. The equipment and alterations will augment the overall safety of the suite for WNPRC personnel and will improve the quality of the veterinary care for, and data collected from, the nonhuman primates housed within the suite.